Effects of Weekly or Intermittent Dosing Regimens of Signaling Pathway Inhibitors

This task order is designed to determine the relative effectiveness (as cancer chemopreventive agents) of EGFr, MEK, and PI3K inhibitors administered on various schedules. This information will be used as a guide in designing clinical trials of these agents.